Quantitative Photoacoustic Imaging Biomarkers for Characterization of Thrombosis

PROJECT SUMMARY
Thrombosis is the major underlying pathology that causes many cardiovascular diseases including stroke,
ischemic heart disease, and venous thromboembolism (VTE). VTE, which includes both deep vein throm-
bosis (DVT) and pulmonary embolism, is the third most common cause of death in the world, to coronary
heart disease and ischemic stroke and is responsible for more than 500,000 deaths in the US each
year. Imaging methods to diagnose VTE include compression ultrasonography, computed tomography
pulmonary angiography (CTPA), or ventilation-perfusion lung scanning. However, each of these imaging
methods are qualitative and do not offer a method to determine the type or age of the thrombus, only
visualize its presence or absence. Treatment for these conditions varies depending on the thrombus type;
therefore, the development of non-invasive diagnostic tools to characterize clot microstructure is critical to
the selection of proper treatment and clinical pathways.
Photoacoustic imaging, which relies on the acoustic response from tissue after the absorption of pulsed
light, is a promising method to both visualize and characterize thrombi. The photoacoustic signal depends
on the optical absorption properties of the imaged tissue which vary across wavelengths of light, but exist-
ing methods rely on either a single optical wavelength or on differences between the clot and surrounding
blood and do not attempt to fully characterize the clot or understand the underlying microstructure. We
hypothesize that there is rich acoustic and optical information present within blood clots that can be ex-
tracted and quantified using photoacoustic imaging. Therefore, driven by a team of primarily undergrad-
uate researchers, we will characterize the unique optical properties of biological chromophores relevant
in thrombus formation (Aim 1) and develop algorithms to quantitatively measure blood clot composition in
photoacoustic imaging (Aim 2).
These studies will establish a foundation for quantitative photoacoustic characterization of thrombosis
and develop quantitative monitoring tools to non-invasively diagnose and track thrombus composition over
time. With these tools, we envision improved, targeted therapies resulting in faster treatment and improved
patient outcomes. Furthermore, this project will have a significant impact on the undergraduate research
landscape at Oakland University, supporting the involvement of at least five undergraduate researchers
over the project’s duration.

Public health relevance
PROJECT NARRATIVE The development of non-invasive diagnostic tools to characterize the microstructure of thrombi (i.e., blood clots) is critical to the selection of proper treatment and clinical pathways for many cardiovascular diseases including stroke, ischemic heart disease, and venous thromboembolism. Driven by primarily undergradu- ate researchers, we will characterize the unique optical properties of biological chromophores relevant in thrombosis and develop algorithms to quantitatively measure thrombus composition using photoacoustic imaging. These tools will ultimately lead to targeted thrombosis treatment, resulting in rapid determination of treatment path and ultimately improved patient outcomes.